Biophysical and functional coupling of protein condensates to ordered lipid domains in T-cells

Project Summary
T-cells integrate complex signals to make accurate decisions for activating immune responses, including
cytokine secretion, degranulation, and proliferation. This integration requires precise regulation of signaling
proteins at the cell membrane. Recently, we demonstrated that key membrane-associated T-cell signaling
proteins are organized into condensed protein assemblies that regulate signal transduction. Namely,
phosphorylation of the transmembrane adaptor protein Linker of Activation of T-cells (LAT) induces multivalent
interactions with cytoplasmic adaptors that produce biomolecular condensates. This condensation is required
for T-cell signal transduction. In parallel, we have shown that LAT, through its transmembrane domain,
associates with cholesterol-driven lipid nanodomains called lipid rafts, which have also been heavily implicated
in immune cell signaling. The involvement of LAT in both lipid nanodomains and cytoplasmic protein
condensates suggests its potential to functionally couple these aspects of cellular organization. Combining
expertise in lipid domains and protein condensates, our preliminary observations demonstrate that protein
condensates can recruit membrane domains and promote their formation. Further, we find that this raft-
condensate coupling is required for T-cell activation. These observations prompt fundamental questions about
the biophysical mechanisms of coupled phase separation between the cytoplasm and membrane and its
consequences in T-cell signaling. We will explore these questions with an integrated approach, spanning from
biophysical characterization of purified systems to signaling and advanced microscopy in live T-cells. Aim 1
examines LAT-mediated coupling between protein condensates and membrane domains. In both model
membranes and living cells, engineered protein probes and fluorescent lipid reporters are used to examine the
biophysical properties of condensate-associated membranes. We also evaluate how condensates can change
protein affinity for membrane domains. Aim 2 explores how LAT condensates regulate membrane organization.
T-cell plasma membranes and cytoplasm both lie near phase coexistence boundaries and are thus poised for
large-scale structural rearrangements. We investigate the hypothesis that protein condensates regulate lateral
lipid organization. We report novel observations of micron-scale cholesterol-rich domains in activated T-cells
and explore their basis and consequences. Further, we evaluate electrostatic interactions between condensates
and lipids to reveal how condensates sort lipids and proteins in the membrane plane. Finally, preliminary data
show that coupling of LAT condensation with membrane domains is essential for signal transduction leading to
T-cell activation. Aim 3 will dissect the molecular mechanisms through which condensates and ordered domains
cooperatively regulate signal propagation from the T-cell receptor. Together, these studies aim to reveal
biophysical principles involved in membrane organization, signal transduction, and ultimate activation of T-cells.

Public health relevance
Project Narrative (Public Health Relevance) T-cells must integrate diverse signals to make accurate decisions about when and how to activate an immune response, and this precise signal integration is mediated in part by the condensation of signaling proteins into droplet-like compartments that organize and stimulate signaling. We have discovered that these droplets are coupled to liquid membrane domains, which themselves play important roles in organizing signaling. This proposal investigates the physics, biochemistry, cell biology of how this coupling of organization principles controls T-cell signaling and activation.